Self Stigma Reduction for African Americans Living with HIV/AIDS

DESCRIPTION (provided by applicant): In 2004, the Centers for Disease Control reported that AIDS was the leading cause of death for African- American women between the ages of 25 to 34 and African-American men between the ages of 35 to 44 in the United States. Researchers have explained these ethnic/racial disparities in terms of delays in accessing care and difficulties in adhering to medication regimens. These findings suggest that culturally appropriate interventions developed to reduce HIV/AIDS stigma could help improve treatment adherence and in turn, improve health outcomes for African-Americans living with HIV/AIDS. It is the career aspiration of Dr. Rao, applicant for this Patient Oriented Research Career Development Award (K23), to help lessen the burden of stigma associated with HIV/AIDS in vulnerable populations. In this proposal, Dr. Rao outlines a career development plan that will lead to a line of work aimed at making available an effective, culturally- appropriate intervention to reduce self stigma for African-Americans living with HIV/AIDS. Through coursework and mentorship, Dr. Rao will train in culturally-specific models of health beliefs and advanced qualitative and quantitative research methodologies. She will implement a research project that will adapt a self stigma reduction intervention for African-Americans living with HIV. In addition, she will adapt and validate an outcome measure of self stigma for use in a future clinical trial. These adaptations will lead to a pilot test and then directly to a full-scale clinical trial of the intervention. Drs. David Cella and Patrick Corrigan, senior investigators with extensive experience in behavioral interventions and patient reported outcomes measurement, will serve as co-sponsors for this project. The clinical site for this project, the outpatient HIV Clinic at Northwestern Memorial Hospital, serves a patient population with much ethnic/racial and gender diversity, and its patients enthusiastically participate in clinical research. During the award period, Dr. Rao will be based at Evanston Northwestern Healthcare and have faculty appointments at Northwestern University. Her location at these institutions, with their outstanding reputation in research and education, will provide her with an outstanding environment, rich with the research resources she will need to become an independent investigator. Dr. Rao will be uniquely positioned to carry out this work aimed at reducing HIV stigma, and subsequently improving health outcomes, for African-Americans living with HIV.